C. albicans invasive growth

The human fungal pathogen C. albicans causes life-threatening systemic infections and severe
morbidity from mucosal infections. Morphology switching between budding and filamentous growth
is central to C. albicans pathogenesis. The transition to hyphal growth makes C. albicans a more
aggressive pathogen that can infect a broad range of host niches by crossing epithelial and
endothelial barriers and growing invasively into tissues. However, most previous research has
focused on identifying upstream regulators and genes that promote hyphal growth in liquid culture,
which are often not important in vivo. Therefore, little is known about the mechanisms that directly
promote invasive growth of C. albicans in the host. To address this gap, a genetic screen was
used to identify mutants that are strongly defective in invasive growth. The proposed studies will
focus on three sets of these mutants that revealed new mechanisms that are critical for invasion.
Aim 1 will focus on mutants that identified an important role for endocytosis in invasive growth in
vitro and in vivo. These studies are expected to reveal which stages of endocytosis are important
and how they promote plasma membrane organization that is needed for invasive growth. Aim 2
will focus on two other newly discovered functions that mediate novel mechanisms for invasion.
One new function is carried out by Pxl1, which is similar to paxillin proteins that bind stressed actin
filaments to mediate mechano-sensing in mammalian cells. The pxl1D mutant will be investigated
to determine how it plays a role in sensing the surrounding matrix and mediating invasive growth.
The other new function needed for invasive growth involves pathways that regulate trafficking of v-
SNAREs, which are needed for secretion. Defining the role of these trafficking pathways will be
significant because polarized secretion is fundamentally important for hyphal growth. The new
mechanisms will be tested in mouse models of oropharyngeal candidiasis and bloodstream-
disseminated candidiasis to determine how invasive growth is regulated at these very different
sites. Identifying the mechanisms that promote C. albicans invasive growth will create new
avenues for the development of therapeutic approaches.

Public health relevance
Project Narrative New medical treatments and an aging population are increasing the pool of individuals that are susceptible to infections caused by the human fungal pathogen Candida albicans. Better therapeutic approaches are needed to treat C. albicans infections due to the limitations of current antifungal drugs and the emergence of drug resistant strains. The proposed studies will identify novel mechanisms that promote invasive growth of C. albicans into tissues, which can then be targeted in future studies to identify new antifungal strategies.